Cilia in Heart Development and Disease

Congenital Heart Disease (CHD) is the most common birth defect affecting 1% of all live born infants. While
~90% of patients with CHD survive into adulthood, there are many comorbidities that make CHD an
increasingly significant public health problem. Genomic analyses of large cohorts of CHD patients have
identified a significant genetic contribution to CHD, but the link between etiology and clinical outcome remains
an important question. When I began my search for the cause of CHD, I identified the cilium as being central to
left-right (LR) axis and cardiac development, and most recently, as part of the Pediatric Cardiac Genomics
Consortium (PCGC), identified significant contributions from mutations affecting cilia and chromatin remodeling
genes to human CHD. However, the question of how cilia dysfunction precisely influences CHD remains
unanswered. I have assembled a group of co-investigators with expertise in mouse and zebrafish
development, live-cell imaging, optogenetics and genomics to take a multi-pronged approach to understanding
the central role of the cilium in heart development with the long-term goal of leveraging this data with ongoing
genomic and clinical studies to improve clinical outcomes of CHD. First, we will resolve the long-standing
question of how cilia instruct cardiac LR asymmetry. We will use single-cell RNAseq to define the cellular
composition of the left-right organizer (LRO), a transient ciliated organ that is essential for instructing cardiac
asymmetry. We will then establish the molecular mechanism linking cilia signaling at the LRO to cardiac LR
development in mouse and zebrafish embryos. Together these experiments will uncover the mechanism by
which an embryo determines LR asymmetry, and provide gene sets that will inform the search for human CHD
candidate genes. Second, we will investigate the role of cilia in cardiac valve formation. We have found
dynamic, flow-sensitive cilia in the presumptive atrio-ventricular valve region of the zebrafish heart, and will test
the hypothesis that valve specification is driven by the mechanical forces occurring at interfaces between
differentially contracting chambers, and that valve cilia are the mechanotransducers leading to changes in
transcription of klf2/klf4 and downstream valve morphogenesis. Third, we will unravel the mechanism by which
epigenetic factors influence cardiac development. The important role of chromatin remodeling genes in human
CHD has raised the question whether any of these transcriptionally regulate cilia in heart development. We
have already found that histone H2B monoubiquitination (H2BUb1) transcriptionally regulates cilia function at
the LRO. We are now testing how H2BUb1 affects cardiac development in mouse embryos and human iPSC-
derived cardiomyocytes through cilia-dependent and/or cilia-independent mechanism(s). Our long-term goal of
translating the basic biologic and genomic data to clinical impact will be addressed by returning mechanistic
and genetic data from our cilia work to the PCGC CHD genomics project so that the resulting discoveries lead
to personalized medicine for patients with CHD.
!

Public health relevance
Project Narrative Congenital heart disease affects 1% of all liveborn infants, and is the most common major birth defect. Cilia are antenna-like structures that extend from almost all cells to obtain and interpret information from the extracellular environment, and abnormal cilia are known to cause congenital heart disease. This proposal investigates how cilia instruct normal heart development, and how abnormal cilia can impact patients with CHD.